THERAPY FOR ALCOHOL USE DISORDER

Abstract
Alcohol use disorder (AUD) is a major global health issue. In the US, AUD affects over 14 million people over the
age of 18. While there are three approved drugs for AUD, less than 4% of patients eligible for pharmacotherapy
are prescribed a medication – likely due to limited efficacy of currently approved agents. Also, the relapse rate
for AUD continues to be exceedingly high. Thus, new therapies are urgently needed for AUD. Both preclinical
and clinical evidence suggest that antagonism of the type 1 cannabinoid (CB1) receptor is a promising strategy
for AUD. However, first generation CB1 blockers produced adverse psychiatric effects in ~6% of patients making
them unsuitable for chronic use. Artiam Bio is developing second generation CB1 blockers that are designed to
be efficacious without producing adverse psychiatric effects. Artiam Bio’s approach takes into consideration that
intrinsic activity of the CB1 receptor is required for emotional welfare, and that first-generation full inverse
agonists/antagonists like SR141716A (rimonabant) completely abrogated this necessary beneficial process. The
compounds developed by Artiam, including its lead molecule and backup, are high affinity but low intrinsic
efficacy partial inverse agonists that preserve basal activity of the CB1 receptor – thereby reducing the
potential of adverse neuropsychiatric events. Supportive evidence comes from rodent studies presented in this
application. For this Phase 1 STTR application, Artiam’s team will partner with investigators from University of
North Carolina’s Bowles Alcohol Research Center to perform efficacy studies with its lead compound in a rat
model of alcohol consumption and relapse. Further, additional behavioral studies are proposed in anxiety-prone
mice using a chronic dosing regimen to further de-risk Artiam’s lead compound for clinical development.
Successful completion of these studies will pose Artiam’s lead compound, which has good drug-like properties,
for clinical development to treat AUD.

Public health relevance
PROJECT NARRATIVE We have developed specialized blockers of the type 1 cannabinoid receptor. We will test one such compound for alcoholism, which is a major problem. In addition, we will do studies to de-risk this compound for eventual clinical development.